Development of humanized microbiota mouse models of ME/CFS

Project Summary/Abstract
Our preliminary data, as well as our previous published studies, show that ME/CFS cases have alterations in
gastrointestinal mucosal immunity and mitochondrial homeostasis. Several other studies have described
significant alterations in the composition of the gut microbiome in ME/CFS cases, when compared to age and
gender-matched controls, potentially implicating a pathological role for a dysbiotic microbiota in the progression
of ME/CFS through the gut-microbiota-brain axis. We hypothesize that by conducting a fecal microbiota
transplantation (FMT) with stool from ME/CFS cases into mice that are engrafted with a functional human
immune system, we can develop an animal model that will replicate ME/CFS-associated pathology. We further
hypothesize that this model can be used to conduct ME/CFS research that is not practical or possible when
working with human subjects.
In Specific Aim 1, we will characterize and transplant stool from ME/CFS cases and healthy controls into
common C57BL/6J laboratory mice, which have a normal murine immune system, as well as mice that are
engrafted with a functional human immune system. We will then evaluate these mice for exercise intolerance,
neurocognitive dysfunction, and sleep disturbances; behavioral alterations consistent with those observed in
human cases. In Aim 2, we will pathologically evaluate these mice to identify changes in the gut and the brain
that potentially implicate the altered microbiota in ME/CFS pathophysiology. These studies will lay the
foundation for a larger research focus to identify ways to target the gut-microbiota brain axis in the prevention
and treatment of ME/CFS.
ME/CFS is a multisystemic, debilitating, and neglected illness for which no accepted efficacious treatments are
currently available. Population-based epidemiologic studies suggest that ME/CFS may affect as many as 2.5
million people in the United States alone. Moreover, ME/CFS produces an annual economic burden of at least
$17 billion 4. Although ME/CFS represents a serious public health concern, after almost four decades of research,
the pathophysiology of this illness is still largely unknown.

Public health relevance
Project Narrative Several lines of evidence suggest that a gut-microbiota-brain axis connection is involved in the pathophysiology of ME/CFS. Mice that received fecal transplants from human donors with other neuroimmune diseases present with behavioral alterations consistent with these diseases, suggesting that fecal transplants may be used to create humanized mouse models of ME/CFS. Therefore, we propose to develop humanized mouse models of ME/CFS by using stool from ME/CFS subjects and healthy controls. Fecal transplants will be made using C57BL/6J mice and Hu-CD34+ NSG-SGM3 transgenic mice engrafted with a human immune system. We will then evaluate these mice for behavioral alterations and mucosal and neuroimmune alterations consistent with ME/CFS.